AMF - SR Component

ADVANCED MICROSCOPY FACILITY (AMF) – PROJECT SUMMARY
The ability to visualize the biological processes that contribute to the transformation of a normal human cell
into a pathogenic cancer cell can provide cancer researchers with the critical insight that might lead to the
development of a new cancer therapy. The overall objective of the Advanced Microscopy Facility (AMF) is to
support rigorous and reproducible imaging experiments to help foster these discoveries. To do this, the AMF
provides imaging expertise and access to well-maintained, state-of-the-art instrumentation for University of
Virginia Cancer Center (UVACC) Members. The AMF personnel provide extensive imaging expertise and
support imaging experiments from conception to data interpretation. Finally, the AMF provides training and
education in imaging best practices and can serve as a resource for imaging rigor and reproducibility for the
cancer research community at UVA.

Public health relevance
Project Narrative: Per PAR-20-043, Project Narrative is not completed.